Mitigation of hematopoietic acute radiation syndrome (ARS) by inhibition of tyrosine kinase Fgr

Ionizing radiation (IR) causes acute damage to both hematopoietic (H) and gastrointestinal (GI) systems. The
hematopoietic system damage is known as the acute hematopoietic radiation syndrome (H-ARS). There are few
FDA approved therapies to treat H-ARS that can be given after 24h. Therefore, there is an urgent need for novel
medical countermeasures (MCMs) targeting master regulators of inflammation, proliferation, and tissue
regeneration in response to TBI injury. We have discovered a novel target of H-ARS Fgr, a non-receptor tyrosine
kinase that is a master regulator gene that promotes inflammation in the bone marrow after TBI. In our
preliminary data we show: 1) Significant increase in survival of Fgr knockout (Fgr-/-) mice after total body
irradiation (TBI); 2) Complete survival of mice that received Fgr-inhibitor, TL02-59 treatment 24h after TBI; 3)
Induction of proteins that protect ARS including G-CSF and GM-CSF following TBI in Fgr-/- mice bone marrow
relative to control mice, 4) The Fgr-/- bone marrow is more radioresistant evidenced by the survival assay of
CFU-GEMM colonies; 5) reduced post-TBI upregulation of inflammatory proteins in the bone marrow of Fgr-/-
mice, 6) Fgr inhibitor TL02-59 reduced the secretion of inflammatory proteins from irradiated cells, 7)
Identification of CD91 as receptor upstream of Fgr, and 8) Genetic ablation of CD91 phenocopies Fgr inhibition
by TL02-59. We hypothesize that Fgr is a master regulator of inflammation. TBI causes massive cellular
necrosis and release of endogenous ligands of CD91 and induction of Fgr. Engagement of CD91 by its ligands
leads to significant activation of Fgr in the bone marrow cells which induces the release of a battery of
inflammatory cytokines, immediate systemic inflammation, and further cell death. We further hypothesize, that
Fgr inhibition by TL02-59 or antagonizing CD91, would lead to suppression of inflammation, recovery of bone
marrow, and improvement in survival. We will use a 1) our novel inducible Fgr knockout (cFgr-/-) mouse model,
conditional CD91 knockout (CD91-/-) mice, hematopoietic specific Fgr knockout (H-Fgr-/-) mice, and a small
molecule inhibitor of Fgr TL02-59 as a new approach towards developing a novel MCM after TBI. We will
test the hypothesis that following irradiation, induction of Fgr mediates inflammation and cell death, and
inactivation or inhibition of Fgr after 24h, directly or indirectly, will significantly increase survival by mitigating H-
ARS. We will investigate upstream and downstream targets of Fgr and delineate underlying mechanism of
hematopoietic protection by Fgr inhibition. In Aim 1, we will first Establish that genetic ablation or pharmacologic
inhibition of Fgr mitigates H-ARS. In Aim 2, we will Establish the mechanism of ARS mitigation by TL02-59 is
from H-ARS mitigation, and in Aim 3, we will Establish the link between Fgr and inflammation in TBI mice.
Successful completion of the proposed Aims would lead to the discovery of a most potent mitigator of H-ARS yet
reported. The Fgr inhibitor, TL02-59 mitigates H-ARS in 100% of treated mice at 24 h after TBI. A drug that
inhibits the function of one protein indicates that it is a master regulator of the H-ARS.

Public health relevance
Exposure to total body irradiation (TBI) could occur from a nuclear accident or attack, or from cancer radiotherapy. Ionizing radiation (IR) causes acute damage to both hematopoietic (H) and gastrointestinal (GI) systems. We have discovered a novel target of H-ARS, a non-receptor tyrosine kinase Fgr, that we propose, is a master regulator gene promoting inflammation in the bone marrow after TBI. In mouse models, using a potent inhibitor of Fgr TL02-59 will our goal is to mitigate ARS following TBI after 24 hours and propose a new medical countermeasure.